Role of IL-33 in KRAS and STK11 mutant non-small cell lung cancer

Background and innovation
Non-small cell lung cancers (NSCLC) with loss-of-function of STK11 and oncogenic KRAS
mutations are less likely to respond to anti-cancer immunotherapy. How loss of STK11 reduces
the effect of checkpoint inhibitor immunotherapy and the role of mutant KRAS in NSCLC is
poorly understood. Our preliminary pre-clinical data suggest a role for tumor derived interleukin-
33 (IL-33) interacting with the host’s immune system, and deleting IL-33 from tumor cells results
in slower tumor growth. The proposed translational project aims to use a previously developed
novel mouse model with an intact immune system, required for testing of immunotherapy, and
implantation of genetically defined, well characterized NSCLC cells with consistent growth
patterns to 1) establish a causal link between STK11 mutations and tumor production of IL-33;
2) determine which cells are responsible for responding to tumor produced IL-33 in promoting
more rapid tumor growth; 3) test whether blocking IL-33 throughout the whole body has similar
effects to preventing tumor cells specifically from releasing IL-33.
Significance and Impact to Veterans Healthcare
By leveraging the existing infrastructure of the Lung Precision Oncology Program and support of
the National Precision Oncology Program for routine comprehensive genomic testing of early-
stage lung cancers, a network of five Veterans Affairs Medical Centers in the New York
metropolitan area and other VA sites nationwide will provide sufficient samples of NSCLC
specimens with STK11 and KRAS alterations from Veterans who are treated with surgical
resection of their lung cancer.
Path to translation
Successful completion of this project will not only drive human clinical trials to test whether
targeting IL-33 may work in NSCLC, but will also add to the knowledge of basic tumor biology,
including the role of STK11 and IL-33 in NSCLC. Furthermore, this project may establish IL-33
as a biomarker predicting response or even harm to immune checkpoint inhibitors, and if a cell
type response for promoting tumor growth is successfully identified could lead to novel
treatments for NSCLC.

Public health relevance
Lung cancer remains a leading cause of cancer deaths among US Veterans, compounded by the increased frequency of tobacco use and military-specific exposures such as Agent Orange. While some Veterans afflicted with a specific type of lung cancer (non-small cell lung cancer, or NSCLC) have long-term control with new treatments, far too many US Veterans still succumb to this deadly disease. Advances in specialized genetic testing of lung cancers have found that lung cancers missing a working STK11 gene makes the tumor more resistant to treatment. Pre-clinical data have found increased level of a signaling molecule, interleukin-33 or IL-33, in lung cancers missing STK11, and disrupting IL-33 from NSCLC tumors in mice prolonged their survival. Successful completion of this project may lead to clinical trials testing a new treatment strategy targeting IL-33 for NSCLC, and contribute to the general knowledge base of how STK11 and KRAS control lung cancer growth.